INSULIN EFFECTS ON INTRAMUSCULAR FATTY ACID METABOLISM

Intramuscular TFGA are 2-4 fold greater in insulin resistant, obese than in lean, insulin sensitive humans. These enlarged lipid stores are proposed to contribute to skeletal muscle insulin resistance vi the glucose fatty acid cycle. Endurance trained humans also have increased intramuscular TGFA, however, and are not insulin resistant. If intramusclar FA contibute to insulin resistance, intramuscular TGFA kinetics must be regulated quite differently in these two groups. The differences could be present under basal conditions in response to insulin or both. We anticipate that basal intramuscular TGFA hydrolysis will be increased in visceral obesity in proportion to the increased TGFA stores, and that hydrolysis rates will not be inhibited by insulin in this group. The results will provide the first available information regarding the kinetics of intramuscular FA in humans and will help us to understand the role of this small, but potentially important lipid pool in the syndrome of insulin resistance/visceral obesity.